3T GE SIGNA Premier XT MRI

PROJECT SUMMARY/ABSTRACT
This proposal is a request for a 3 Tesla, whole-body, wide-bore magnetic resonance imaging system for the
University of Colorado Anschutz Medical Campus School of Medicine. The proposed instrument, a 3T GE
SIGNA Premier XT, would fulfill unmet research needs while providing greater scientific and funding
opportunities for investigators across a wide range of departments and institutions. Major research interests of
our investigators include understanding the neurobiology of obesity and food intake behaviors, substance use
disorders, psychiatric and neurodevelopmental disorders, and fetal exposures to stress or environmental
factors, as well as non-neuronal mechanisms of metabolic disorders and kidney function. In the context of our
expanding research enterprise, our current scanner is oversubscribed, leading to a need for additional
scanning capacity. Additionally, the increased capabilities of the proposed scanner, which include substantially
improved gradient performance compared to our current Siemens 3T MRI scanner, would be highly beneficial,
as it would allow improved image quality (higher signal-to-noise, reduced distortion and artifacts in many types
of scans) and enable performance levels compatible with current standards of large-scale neuroimaging
consortiums. Importantly, this improved gradient performance can be achieved in a wide-bore system, a
feature that remains critical for our investigators, given the large number of studies focused on obesity and
related disorders. The requested scanner is also quieter, with reduced vibrations. This would benefit all
studies, as it improves participant comfort and compliance. This is especially useful for studies focused on
psychiatric disorders, in which our investigators often assess auditory processing, which is limited by the loud
noise generated by our current scanner. Quieter scanning would also benefit research investigating
neurodevelopment in infants, who have to be able to sleep during scanning. Higher acceleration factors on the
new scanner would allow for shorter overall exam times, additionally increasing the likelihood of scan
completion in infant and pediatric populations. These factors would also result in less geometric distortion and
signal dropout in many of the brain regions studied by our investigators. Multiple other benefits of the proposed
system, including enhanced overall homogeneity, more receiver coils, better analog-to-digital converters,
improved reconstruction, including the capability to run Deep Learning and Artificial Intelligence-based
reconstruction, improved processing speed, and the availability of AIRTM coils will also yield myriad
improvements in data quality, participant comfort, and compliance. These upgrades will improve our
investigators’ ability to innovate, collaborate, and make important contributions to science.

Public health relevance
PROJECT NARRATIVE The proposed 3 Tesla, whole-body, wide-bore magnetic resonance imaging system (3T GE SIGNA Premier XT) would fulfill unmet research needs at the University of Colorado Anschutz Medical Campus while providing greater scientific and funding opportunities for investigators across a wide range of departments and institutions. Specifically, the new system would provide much needed additional scanning capacity and offer higher signal-to-noise ratios, less distortion, shorter exam times, facilitate substantially quieter scanning, and allow access to newer imaging techniques not available on our current platform. These benefits will be particularly important for research involving behavioral health, obesity/metabolic disorders, and neurodevelopment.